Meeting the cost and privacy demands for detecting Anabolic Androgenic Steroid doping in youth athletics with rationally designed nuclear receptor BioAssays

Project Summary
This SBIR project concerns the validation of a novel measurement platform to identify persons, particularly
youths, using testosterone and testosterone-like drugs. These Anabolic Androgenic Steroids (AASs) are
Schedule III controlled substances with high rates of unsupervised, illicit use. In the US, AAS use by the
general public has a lifetime prevalence of 6.4% for males and 1.6% for females.
AASs are referred to as Appearance and Performance Enhancing Drugs (APEDs) for their perceived benefits
to physical appearance and/or athletic prowess. Media attention has focused on elite athletes caught ‘doping’
by national anti-doping monitors. Less publicized is the 1.3% of US grade 12 males, including unmonitored
youth athletes, who in 2022 reported AAS abuse within 30 days of being surveyed.
There are technical, sample collection/shipping and cost impediments that prevent testing of pay-to-play
amateur athletes using the urine-focused methods developed for elite athletes. XCellAssay developed an
amateur-compatible method in which a high throughput Androgen Receptor (AR) BioAssay quantifies the
levels of all androgens in just µl’s of blood, dried on a filter paper and added to a micro-well in a 384-well plate.
XCellAssay’s proprietary Internal Control Receptor (ICR), measured in the same well, detects intermediates of
the steroid synthesis pathway that decrease when doped steroids activate negative feedback controlling
steroid homeostasis. This study is designed to show if the expected decrease in ICR ‘intermediate steroids’,
relative to AR ‘androgens’, is sufficient to reliably identify individuals receiving supplemental androgens.
In preliminary studies, the ICR/AR measurement ratio was consistent in 12 sera from presumably ‘clean’ adult
males over the full natural range in androgen concentration. In the proposed Phase I project, large numbers of
deidentified blood samples will be obtained from commercial biobanks for an appropriately powered study of:
Aim 1 the natural age- and gender-specific variations in ‘normal’ ICR/AR BioAssay activity ratios and
Aim 2, whether clinical testosterone supplementation reliably reduces ICR/AR measurement below the lower
margin of ‘normal’. The reliability in ICR/AR detection of ‘doping’ in blood will be assessed also by direct
comparison to matched urine samples measured using the currently established ‘doping’ detection protocols.
The Phase I Specific Aims will rapidly validate, or not, the performance of the ICR/AR BioAssay ratio as a
doping detection tool. If Phase I milestones are attained, Phase II would develop the final collection kit and
would broadly compare the ICR/AR and the current doping-detection protocols on blood/urine collected from
random athletes, a low percentage of whom will have doped with any of a number of AASs. The goal is to
define if the ICR/AR BioAssay can reliably detect androgen doping at the <$30/sample (collection/shipping/
measurement/ reporting) needed to be compatible with the cost and testing requirements for high-caliber,
youth amateur athletics.

Public health relevance
Narrative The misuse of Anabolic Androgenic Steroids (AASs) receives widespread attention for its impact on ‘fair competition’ in elite athletics, but the health consequences of unsupervised and excessive AAS use is substantive in all populations. Youths are particularly vulnerable to the allure of these ‘Appearance and Performance Enhancing Drugs’ and developing youth bodies are even more susceptible to the health consequences of these powerful hormone mimics. A widespread AAS monitoring system, applied institutionally across organized youth athletics, is anticipated to reduce AAS abuse within the youth population.